TREATMENT OF CHRONIC HEPATIS B VIRUS INFECTION WITH ALPHA INTERFERON

To evaluate the effects of frequency dosing of alpha interferon in relationship to resolution of chronic hepatitis B infection and conversion of antigen positivity.